THERAPEUTIC TRIAL TREATMENT OF OBSTRUCTIVE SLEEP APNEA

The aims of this study are to determne if the clinical and oximetry basis for the diagnosis of obstructive sleep apnea is verified by ambulatory recordings, and to determine if a therapeutic trial of continuous positive airway pressure (CPAP) effectively corrects the measured ventilatory abnormalities seen in obstructive sleep apnea as measured by ambulatory recordings.